Cancer Prevention and Control Research Program

CANCER PREVENTION AND CONTROL (CPC) PROGRAM: PROJECT SUMMARY
The goal of the Cancer Prevention and Control (CPC) Program is to foster scientific discovery across the cancer
continuum that translates into clinical, community, and policy strategies to improve cancer outcomes. Although
organized under several names during the past 50 years, cancer prevention and control research has been a
foundational program of the Wake Forest Baptist Comprehensive Cancer Center (WFBCCC) since its first
Cancer Center Support Grant Award in the 1970s. Currently, the CPC Program is the largest WFBCCC Program,
with 45 scientific members representing 16 departments. The CPC Program is led by Eric Donny, PhD, and
John Salsman, PhD who guide the scientific direction of the Program and the integration of CPC research with
other WFBCCC Programs. Members prioritize research relevant to the WFBCCC catchment area and Center-
wide strategic priorities, most notably: Tobacco, Health Disparities, and Survivorship. The CPC Program
conducts rigorous and translatable research across three Specific Aims: (1) Improve health behaviors
associated with reduced risk of cancer incidence, morbidity, and mortality; (2) Enhance quality of life and reduce
symptom burden for survivors through the development of optimal supportive care interventions; and (3)
Advance cancer care delivery by discovering strategies to improve the effectiveness and implementation of best
and promising practices across the continuum of care. These scientific foci guide CPC programmatic strategies,
which include hypothesis-driven research tied to catchment area needs; integration with key institutional
resources; collaboration with other WFBCCC Programs, regional National Cancer Institute-Designated
Comprehensive Cancer Centers, and community partners; and organizational strategies that promote the
scientific vision and aims of the CPC Program. Since the last renewal, CPC Program investigators have made
major contributions to the science of tobacco control; implementation of smoking cessation interventions;
determinants of emerging risk factors for cancer, including alcohol use, obesity, and physical activity; disparities
in survivorship care; digital health interventions; patient-reported outcomes and quality of life; adolescent and
young adult survivorship; implementation science; and low-dose CT screening. The CPC Program is the primary
scientific home for the Wake Forest NCI Community Oncology Research Program Research Base (WF-NCORP-
RB), the ECOG-ACRIN NCORP Research Base, a new NCI P50 Implementation Science Center on Cancer
Control, and a multi-institutional NIDA U54 on tobacco regulatory science. In 2020, CPC Program members
received a total of $13M in cancer-focused, peer-reviewed funding (direct costs), of which $8M (62%) was from
NCI and $5M (38%) from other NIH sources. During the current project period, members authored a total of 284
cancer- relevant publications; 87 (32%) were intra-programmatic, 37 (14%) were inter-programmatic, and 24
(9%) were in high-impact journals. In 2020, the CPC Program conducted more than 60 clinical and/or community-
based research studies, and even during the COVID-19 pandemic, over 13,000 participants were recruited.